Uncovering new approaches to manipulate and probe biochemical processes with spatial and temporal precision

While traditional genetic tools will always have their place in the molecular and cellular
biologist’s armamentarium, increasingly scientists require more nuanced and precise tools for
probing biological processes. Over the past 15 years, our group has been developing methods
that allow researchers to acutely perturb biochemical processes, in real time, with fast,
reversible, and tunable control. A focus of our research is the development of tools that utilize
induced protein interactions that can be activated by light or chemicals to control downstream
cellular processes and a variety of protein assemblies, including dimerization, oligomerization,
clustering, and biomolecular condensates. In our ongoing work, we will continue to develop,
validate, and explore the use of novel optogenetic and chemical genetic tools to control protein
function and assembly, extending these tools into new areas. The long term goals of the project
are to enable a set of modular precision tools for probing and manipulating dynamic biochemical
processes, and begin to utilize these tools to uncover new biology with relevance to health and
disease states.

Public health relevance
The proposed research seeks to advance approaches using light and chemical-regulated protein interactions to enable inducible and reversible control over protein assemblies and biological function. The outcome of this work will be highly precise genetic tools for probing and manipulating cellular processes essential for human health.